Career Enhancement Program (CEP)

PROJECT SUMMARY/ABSTRACT – CAREER ENHANCEMENT PROGRAM – (CEP)
The goal of the Career Enhancement Program (CEP) is to recruit promising investigators, at any level of their
career, to prostate cancer research - and in particular - to develop them as exceptional translational investigators.
The CEP focuses on mentoring and supporting exceptional early stage investigators to become outstanding,
independent, and productive translational prostate cancer researchers; as well as supporting senior scientists
who might wish to change career directions to focus on prostate cancer (PCa) research. To support these
researchers’ career objectives, the CEP will leverage the existing mentorship efforts within the UCSF Helen Diller
Family Comprehensive Cancer Center (HDFCCC). This includes utilizing the exceptional group of mentors, all
with successful track records in mentoring and career development, who are current members of the HDFCCC
Prostate Cancer Program, as well as experts from across all UCSF campuses. In turn, the SPORE CEP will
substantially enhance efforts already underway within the HDFCCC by adding significant funding and focusing
on early-career faculty (including advanced post-doctoral fellows transitioning to a faculty position within one
year) who are pursuing innovative translational research in prostate cancer. Drs. Carroll and Chan, highly
qualified senior faculty and translational researchers with strong mentoring track records, will oversee the CEP
as co-Directors of the program. To ensure a successful program aligned with the SPORE goals, they will be
guided under the following specific aims: Specific Aim 1: Recruit and support a diverse group of exceptional PCa
translational research investigators, Specific Aim 2: To provide mentorship and career development support for
early career stage investigators through a formal mentoring program, and Specific Aim 3: Leverage existing
UCSF resources for the career development of early-stage CEP investigators. In summary, the UCSF Prostate
Cancer SPORE CEP will leverage successful extant resources, build upon a rich infrastructure, and provide
substantial institutional funding to develop the careers of future leaders in translational research in prostate
cancer.